Implementation Strategies Addressing Caribbean Stigma to Improve the Woman-to- Woman Cervical Cancer Prevention Intervention

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-CA-
23-036”. The overall objective of the proposed study is to build upon our program of Caribbean stigma research
relevant to cancer prevention. Our preliminary study shows that in the Caribbean, stigma bars preventive care
including cervical cancer screening and HPV vaccination. In response, to address cancer stigma for the
Caribbean contexts, we will employ implementation science approaches to improve the evidenced Woman to
Woman intervention (W2W) to reduce stigma and increase cancer prevention. Rooted in implementation
science, we will be guided by diverse stakeholder perspectives, and the preliminary results of our recent
population-based Caribbean stigma survey (CCSS, N=2233) to enhance the W2W intervention by including a
stigma reduction component to the curriculum. We will leverage our vast African Caribbean Cancer Consortium
(AC3) of community partners including Lay Health Advisors and clinicians to inform and guide the improvements
to W2W using implementation science approaches to enhance the curriculum and strategies of W2W to reduce
cancer stigma, and increase cervical cancer screening and HPV vaccination. To accomplish this objective, we
propose the following specific aims: Aim 1: Informed by our Caribbean Cancer and Stigma Study survey (N=
2233) and qualitative results, using the Evidenced Based Process (EBP) modification strategies to improve the
current W2W intervention with a stigma reduction curriculum. Aim 2: Engage multi-stakeholder perspectives
using community health workers focus groups and clinician interviews to further refine the improved Aim 1 W2W
intervention. We will incorporate cultural stigma consideration and reduction domain and content derived
from the clinician and community health workers; address HPV vaccination improvements, and enhance
implementation strategy to create the enhanced W2W_End Stigma-End Cervical Cancer intervention.
Multi-sectoral stakeholders will ensure W2W_End Stigma-End Cervical Cancer intervention’s cultural
congruence to reduce cancer stigma as a barrier to cervical cancer screening and HPV vaccination. This
implementation science research will be the first to provide novel and requisite stakeholder results to inform co-
created (community advocate, clinician, and researcher) stigma reduction curriculum and communication
strategies for optimal provider and patient activation for increased uptake of cervical cancer screening and HPV
vaccination. Therefore, our study findings will improve the evidenced W2W intervention creating the
W2W_End Stigma-End Cervical Cancer to eliminate stigma as a barrier to cervical cancer screening and
HPV vaccination, for near future Caribbean intervention dissemination.

Public health relevance
PROJECT NARRATIVE Addressing cancer stigma for the Caribbean contexts is urgent but in its infancy; still findings from our population-based study (N=2233) show Caribbean readiness to participate and benefit from our program of stigma research. Hence, leveraging community and clinical partners' input and informed by our stigma survey data, we will employ implementation science to improve the Woman to Woman intervention curriculum and strategies to reduce stigma and increase cervical screening and HPV vaccination.